Transposable Element Mobilization and Disrupted Translational Machinery in Down Syndrome

PROJECT SUMMARY
This R01 proposal outlines a collaborative research initiative aimed at elucidating how mobilization of
transposable elements (TEs) and alterations in mRNA translation disrupt the function of neural progenitor cells
(NPCs) in Down Syndrome (DS). DS, or Trisomy 21, is the most common chromosomal cause of intellectual
disability and is associated with impaired neurogenesis, leading to cortical maldevelopment in early life. Our
data from the human prenatal brain has identified dramatic de-repression of TEs in DS cell subpopulations,
which we have linked to activation of the antiviral innate immune system. Further, we have identified profound
disruption in the mRNA translational machinery, including in many components of RNA granules. Based on this
data, we first seek to map the TE landscape and cellular response in human induced pluripotent stem cell-
derived NPCs, and test interventions to attenuate TE activation. Next, we will investigate changes to the
translatome and proteome associated with DS, identifying novel TE-associated translation events. Finally, we
hypothesize that DS NPCs exhibit significant alterations in the composition of subcellular cytoplasmic
biomolecular condensates – RNA granules – that are critical mediators of mRNA metabolism and translation.
We will map the protein and RNA composition of translation-associated condensates in DS NPCs and
investigate how cytoplasmic phase separation dynamics are altered in DS. The knowledge derived from this
research plan will not only enhance our understanding of the mechanisms through which DS impacts NPC
function, but will also identify targetable pathways for reversing abnormal corticogenesis, offering potential
avenues for intervention and prevention.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it defines mechanisms for impaired neurodevelopment in Down Syndrome, which is a common genetic cause of intellectual disability. Thus, this proposal is relevant to the part of NIH’s mission that pertains to the discovery and application of knowledge to reduce illness and disability.